Adaptation and implementation of a behavioral mHealth intervention to reduce anxiety and depression and end the HIV epidemic in the rural South

ABSTRACT
Untreated anxiety and depression are exceedingly common in people living with HIV (PLWH) in the rural
South, a population critically affected by the HIV epidemic. Addressing mental health is essential to improving
the disparate HIV burden in this population. Yet outside of routine clinical care, few interventions target mental
health in PLWH in the rural South. Mobile health technology (mHealth) and community health worker (CHW)-
delivered care are two intervention models that address barriers unique to rural, underserved, populations.
Dr. Manavalan is an assistant professor in the Division of Infectious Diseases and Global Medicine at the
University of Florida. She seeks a K23 award to gain skills, experience and preliminary data needed to become
an independent physician-scientist focused on developing and implementing novel and scalable interventions in
underserved communities that will contribute to Ending the HIV Epidemic. Through the training and research
proposal outlined in this award, Dr. Manavalan will bridge the fields of HIV and mental health by incorporating
evidence-based interventions effective in other settings into existing medical systems in Florida.
In this 4-year study Dr. Manavalan will adapt an evidence-based CHW-delivered counseling intervention for
delivery through an existing mHealth application, as a strategy to reduce anxiety and depression and maximize
viral suppression in PLWH in the rural South. In Aim 1, she will conduct robust qualitative research with diverse
key stakeholders, guided by the Consolidated Framework for Implementation Research (CFIR), to discern
perspectives to inform adaption and implementation of the intervention. Next, in Aim 2, she will assemble a
Design Consultation Team composed of 12 members from key stakeholder groups (PLWH from the target
population, HIV and mental health providers, and mHealth and behavioral scientists) to assist in adapting CHW-
delivered counseling for mHealth delivery, tailored to a rural population. Adaption of the intervention will occur
iteratively, be informed from data from Aim 1 and will be guided by the ADAPT-ITT framework. Lastly, in Aim 3,
she will pilot the adapted intervention with a type 1 hybrid effectiveness-implementation trial and assess
implementation outcomes (reach, adoptability, implementation, maintenance) and preliminary effectiveness
outcomes (viral suppression, HIV care retention, ART adherence, and anxiety and depression symptoms) using
the RE-AIM model.
The proposed program will enable Dr. Manavalan to gain expertise in 1) adaption and evaluation of
behavioral interventions, 2) mHealth science, and 3) implementation science and hybrid trial design through
mentorship with leading experts, didactic coursework, professional development programs, and application of
research. This study will lay the groundwork for a fully powered R01 trial to evaluate implementation and
effectiveness of the adapted intervention in underserved communities throughout the state of Florida.

Public health relevance
PROJECT NARRATIVE Untreated anxiety and depression are exceedingly common in people living with HIV (PLWH) in the rural South, a population critically affected by the HIV epidemic. However, outside of routine clinical care, few interventions target anxiety and depression in this population. This project aims to address the mental health treatment gap that exists in PLWH in the rural South, by incorporating an evidence-based mental health intervention into an existing mHealth application with the goal of improving HIV care engagement, antiretroviral therapy adherence and maximizing virologic suppression.